Coronavirus Infection Dynamics and Cross-species Transmission in Bats

ABSTRACT
Coronavirus Infection Dynamics and Cross-species Transmission in Bats
Prevention of future zoonotic disease emergence, including pandemic threats, is only possible with a thorough
understanding of infection dynamics in reservoir host populations. The emergence of SARS-CoV, MERS, and
SARS-CoV-2 highlight the need to examine bat-borne coronaviruses in their natural environments. Disease
dynamics and cross-species transmission events in bat populations are complex and remain poorly
understood, despite evidence suggesting that cross-species transmission has shaped coronavirus diversity
and evolution and that viruses with broad host ranges may have increased pandemic potential. Understanding
the longitudinal infection dynamics and the ecological conditions under which coronavirus cross-species
transmission events occur will characterize the processes underlying virus emergence in bats. I hypothesize
that coronavirus cross-species transmission dynamics are driven by host ecology and environmental
conditions.
In Aim 1, I will assess ecological drivers of cross-species transmission of coronaviruses in bats. Using viral
surveillance data standardized across 30 countries with over 50,000 individual bats sampled, I will assess the
likelihood of coronavirus cross-species transmission using an evolutionary Bayesian phylogenetic approach.
Covariates examined will include host-genetic similarity, roost-type, reproductive characteristics, conservation
status, and geographical home-range overlap. Cross-species transmission of bat-borne coronaviruses may
play an important role in increasing the distribution of viruses and pandemic potential.
In Aim 2, I will characterize longitudinal dynamics of coronavirus infections in bats in diverse roost locations. I
will lead local fieldwork in California (USA) to characterize seasonality and diversity of coronavirus infections in
primarily single-species roosts. In Myanmar, I will collaborate with an international team to examine longitudinal
dynamics and additionally assess risk factors for coronavirus positivity. The coronavirus and ecological data
generated will help parameterize models to understand the role of cross-species transmission in outbreak
thresholds, thereby revealing mechanism underpinning viral emergence.
My proposed work has specific relevance towards understanding the dynamics underlying the origins of SARS-
CoV-2 and could inform on future pandemic threats. This study will provide actionable insights into public
health risks, especially for local communities that are most likely to be first exposed to emerging diseases.

Public health relevance
PROJECT NARRATIVE Coronavirus Infection Dynamics and Cross-species Transmission in Bats Newly emerged coronaviruses are a major threat to public health and understanding infection dynamics in reservoir bat hosts has the potential to inform on disease emergence and mitigation of epidemic and pandemic risk. This proposal will investigate host and environmental conditions facilitating cross-species transmission in wildlife sampled across Asia, Africa, and the Middle East. I will also prospectively collect data on bat-borne coronaviruses in diverse ecosystems locally in California (USA) and at an international field site (Myanmar) to assess seasonality, model disease dynamics, and investigate drivers of cross-species disease transmission.